Defining the roles of ACAD10/11 in hydroxy lipid catabolism and metabolic disease

PROJECT SUMMARY/ABSTRACT
Fatty acid β-oxidation (FAO) is a central metabolic pathway of great physiological relevance to human health
and disease. FAO provides fuel for energy production, generates building blocks for the biosynthesis of many
cellular molecules, detoxifies damaging lipids, and produces key signaling molecules. Disruption of this pathway
contributes to fatty liver disease, hypoketotic hypoglycemia, obesity, insulin resistance, type 2 diabetes, and
chronic kidney disease. Importantly, many fatty acids that ultimately are catabolized by FAO are not compatible
with FAO until they have first been modified by other enzymes. These lipids include the 4-hydroxy fatty acids (4-
HAs)—fatty acids that possess an oxidized carbon adjacent to the third, or β, position. Recent analyses
empowered by advances in mass spectrometry have revealed a wide range of 4-HAs and 4-HA precursors in
human plasma, which can originate from dietary intake, lipid peroxidation, and certain drugs of abuse. Prior
analyses in liver revealed that 4-HAs are indeed processed by FAO once they are converted to compatible
substrates. However, the enzymes responsible for this conversion are unknown, and the physiological relevance
of these lipids is largely unexplored. Recently, we identified two atypical, highly uncharacterized FAO-related
enzymes, acyl-CoA dehydrogenase 10 and 11 (ACAD10 and ACAD11), that appear capable of processing 4-
HAs into FAO-friendly substrates via a novel mechanism. The long-term goals of this proposal are to define the
roles of ACAD10 and ACAD11 in the catabolism of 4-HAs and to establish the metabolic ramifications that result
from the disruption of these enzymes. We first aim to establish the specific biochemical reactions catalyzed by
ACAD10 and ACAD11 in vitro through enzymology and structural biology approaches. We hypothesize that
these ACADs employ their unique kinase domain, which is not found in other ACADs, to phosphorylate the 4-
hydroxy position as part of their enzymatic mechanism. We then aim to establish the cellular locations and
activities of each enzyme via microscopy and metabolite tracing studies. We hypothesize that ACAD10 is a
mitochondrial enzyme responsible for the conversion of shorter-chain 4-HAs and that ACAD11 is a peroxisomal
enzyme that converts longer-chain 4-HAs. Last, we aim to reveal the physiological ramifications of ACAD10 and
ACAD11 disruptions in worms, mice, and humans. Notably, ACAD10 and ACAD11 have putative links to
T2DM/insulin resistance, kidney disease, and coronary artery disease via GWAS studies, including in the Akimel
O’odham (Pima Indian) tribe, and mouse models have linked ACAD10 and ACAD11 collectively to insulin
resistance, weight gain, ectopic lipid deposition, and rhabdomyolysis; however, none of these have been studied
directly. We hypothesize that the loss of these enzymes in mice, or the expression of specific ACAD10 variants
in Pima Indians, will result in the accumulation of plasma 4-HAs concomitant with the development of metabolic
complications. Overall, this work aims to establish a fundamental new piece to our understanding of cellular FAO
metabolism and to forge new links between a large, unexplored class of fatty acids and mammalian physiology.

Public health relevance
PROJECT NARRATIVE 4-hydroxy fatty acids comprise a lipid class of emerging importance to mammalian physiology, yet their metabolism is poorly understood. Our work aims to establish the primary enzymes responsible for initiating the breakdown of these lipids and the metabolic ramifications that result from the disruption of these enzymes in cells, worms, mice, and humans. Completion of these goals will add a fundamental new aspect to our understanding of lipid metabolism, link 4-hydroxy fatty acids to specific physiological dysfunctions, and identify potential new therapeutic targets for the treatment of certain disorders related to fatty acid breakdown.